Identifying the interactions between fibro-adipogenic progenitors and the extracellular matrix in skeletal muscle fibrosis

Project Summary/Abstract
Fibrosis is a consequence of a myriad of skeletal muscle diseases including Duchenne muscular dystrophy.
Fibrosis is the pathological accumulation of extracellular matrix (ECM) and impairs muscle function resulting in
a loss of mobility and significant reduction in strength. Muscle resident fibro-adipogenic progenitors (FAPs) are
the key source of ECM deposition in skeletal muscle. Pro-regenerative FAPs support regeneration by
activating in response to injury, depositing ECM to replace the damaged matrix, and releasing pro-myogenic
signals. However, in the context of fibrosis, there is a significant upregulation of a more pro-fibrotic FAP
subpopulation. FAPs activate into myofibroblasts and remain at chronically high levels, leading to excess ECM
deposition. What drives the development of a fibrotic versus regenerative FAP phenotype is not well
understood. The mechanics and architecture of the ECM is altered in fibrotic muscle compared to healthy
muscle, providing mechanical cues to surrounding cells. FAPs are known to be sensitive to these changes in
mechanics and architecture, however, what drives this signaling pathway is not understood. Yes-associated
protein (YAP) is strongly correlated with FAP activation into myofibroblasts on stiff substrates. Blocking YAP
activity is a potential method to manipulate FAP-ECM signaling and reduce myofibroblast activation in the
context of fibrosis. ECM signaling to FAPs may also influence the heterogeneity of FAPs, with the levels of pro-
regenerative and pro-fibrotic FAPs changing during injury and fibrosis. How the subpopulations of FAPs may
be contributing to ECM deposition in fibrosis and regeneration is not well understood. Elucidating the
differential role of FAP subpopulations provides specific targets for anti-fibrotic and pro-myogenic therapies.
Our central hypothesis is that blocking FAPs’ sensitivity to stiff substrates through inhibition of YAP will
reduce the number of pro-fibrotic FAPs resulting in ECM deposition that promotes myogenesis. We will test our
central hypothesis via two aims. In Aim 1, we will inhibit YAP activity in order to determine its role in FAPs’
sensitivity to engineered matrix substrates mimicking the mechanical and architectural features of healthy and
fibrotic ECM. In Aim 2, we will determine the differences in ECM deposition from pro-fibrotic and pro-
regenerative FAPs and its role on myogenesis to assess how the heterogeneity with the FAP population
affects the development of fibrosis and regeneration. Success in these aims will identify the interactions
between FAPs and the ECM in the context of fibrosis, which can be used as targets for anti-fibrotic therapies.

Public health relevance
Project Narrative This research project aims to identify methods to manipulate communication between fibro-adipogenic progenitors and the extracellular matrix in skeletal muscle fibrosis and identify the effect of subpopulations of these cells on fibrosis and regeneration. In the short term, this project will contribute to the understanding of the role fibro-adipogenic progenitors play in the development of fibrosis. In the long term, this work can be used to identify anti-fibrotic targets to stop the progression of fibrosis and improve muscle function.